Bioactive Material Interventions for Ischemic Stroke

PROJECT SUMMARY
Stroke is a leading cause of long-term disability worldwide, and a major consequence of stroke is the doubled
risk of new (incident) dementia for at least a decade afterwards. Ischemia-induced neurodegeneration is a
leading culprit for dementia development and there are currently no therapies to treat or prevent dementia in
the 7 million stroke survivors in the US despite the need. The neurogliovascular unit (NVU) is comprised of glia
(astrocytes), mural (pericytes), and endothelial cells. Following ischemia there is breakdown of the NVU and a
loss of cells (astrocytes and pericytes) responsible for maintaining barrier function in and around the stroke
scar. Urokinase plasminogen activator (uPA) plays a large role in encouraging astrocytes to extend their
processes following an ischemic injury. This process occurs naturally but could be delayed in aging. Platelet-
derived growth factor B (PDGFB) is a top candidate for a therapy as it is critical for recruiting pericytes to seal
vessels and inhibits early angiogenesis. Our goal is to develop a therapy for chronic post-stroke dementia, via
development of an injectable hydrogel with an integrated uPA motif, and plasmid DNA (pDNA) PDGFB-
lipoplexes than will be loaded into the gel for delivery into the stroke scar. I hypothesize neurovascular integrity
will be restored through local uPA interactions promoting astrocytic endfeet coupling and PDGFB release
encouraging pericyte coverage. Emerging data has revealed a prolonged disruption of neurovascular integrity
and appears correlated to greater cognitive decline in humans. We believe restoring neurovascular function will
support improved cognition at chronic timepoints following stroke. We aim to create a gel capable of sustained
retention and cargo release to promote astrocyte and pericyte recruitment over a period for new vasculature to
mature and demonstrate properties of the blood-brain-barrier. The efficacy of our gels and PDGFB-lipoplexes
will be evaluated in a preclinical mouse stroke model, no treatment, delivery of injectable hydrogel without uPA
motif, hydrogel with uPA motif, general hydrogel with control lipoplexes, general hydrogel with PDGFB-
lipoplexes, hydrogel with uPA motif and PDGFB-lipoplexes. Analyses will span immunohistochemical, live
animal imaging, and cognitive and behavioral testing. Along with my strong mentoring team at Stanford
University, and external advisory team, we have created a career development plan to advance my scientific
and academic and professional skillsets. Through this mentored training plan, the MOSAIC K99/R00 will
prepare me to transition to a tenure-track faculty role.

Public health relevance
PROJECT NARRATIVE Stroke impacts about 800,000 people annually in the United States, is associated with progressive cognitive loss attributed to breakdown of the blood-brain-barrier, and survivors have a double risk of dementia in the decade following injury. This proposal aims to develop an injectable hydrogel system to target neurovascular dysfunction by restoring astrocyte and pericyte coverage to restore stabilization and functionality. Developing and deploying strategies to target astrocytes and pericytes could enable novel methodologies for preventing the development of cognitive deficits in stroke-impacted patients.